The 54th Annual Meeting of the American Society for Neurochemistry

PROJECT SUMMARY/ABSTRACT
This R13 application is to request support for the 54th Annual Meeting of the American Society for
Neurochemistry (ASN) to be held April 14-18, 2024 in Portland, Oregon. The total expected attendance for the
ASN 2024 meeting in Portland is ~500. Past NIH financial support for the ASN meeting has been critical for
our goals of enhancing training for future neurochemistry researchers, and for implementing an attractive
educational and professional development program. ASN continues to build its scientific program around four
interwoven, but distinct, themes to accommodate the breadth of neurochemistry and to provide in-depth
analyses of chosen topics: 1) Building the Nervous System, 2) Metabolism and Cell & Molecular Neurobiology,
3) Glial Cell Biology, and 4) Neurodegeneration and Neurodevelopmental Disease. These themes have been
selected to increase our understanding of the cellular and molecular basis of neural development and disease.
Each theme has one of the four Plenary/Presidential speakers and is represented in varying proportions each
year based on the submission of session proposals from the ASN membership and neurochemistry
community. ASN is strongly committed to representation at its meetings by underrepresented racial and ethnic
groups, individuals with disabilities, individuals from disadvantaged backgrounds, and women. While two of the
four Plenary/Presidential speakers and >50% of the Chairs/Co-Chairs/Speakers of Symposia and Colloquia
are female, we are vigilant in trying to identify, encourage, and secure greater numbers from other
underrepresented groups. One of the major goals of ASN is to advance the education and recruitment of early
career investigators. The ASN strongly supports these individuals through travel awards, mentorship, and
various training workshops. In addition, recent representation of trainees/junior faculty in Symposia and
Colloquia has been 40% for Chairs/Co-Chairs and 45% for speakers.
The annual ASN meeting provides participants numerous opportunities to network, collaborate, and exchange
ideas. There is also plenty of time for attendees to congregate informally. Multiple activities are planned during
the meeting to enhance professional development of early career investigators including 1) career development
sessions run by the early career development committee, 2) a student/postdoctoral fellow mingle for networking,
3) lunches with the plenary speakers, 4) participation in Public Forum, High School Day, and the Women in
Neurochemistry lunch event, 5) oral sessions selected from submitted abstracts, with an emphasis on
presentations from trainees, 6) two poster presentations for sharing findings and receiving feedback, 7) to
defray costs of attendance travel awards for outstanding early career scientists are available. This year we have
increased the number of awards and are committed to providing at least 25% of the awards to under-
represented groups as an impetus to further promote and retain diversity, and 8) a job-posting site and
opportunities for trainees to meet with potential future mentors or colleagues. The annual ASN meeting is a one
of a kind scientific conference that brings bring together early career and established scientists to experience
cutting edge neurochemistry and neurobiology and enhances the careers of early career investigators.

Public health relevance
Project Narrative The goal of the 54th Annual Meeting of the American Society for Neurochemistry (ASN) to be held April 14-18, 2024 in Portland, Oregon is to bring together members of the scientific community to bridge and cross-fertilize the fields of neurochemistry and neuroscience. It is imperative to provide early career investigators and trainees, who will ultimately make up the next generation of investigators, with a forum for the open and free exchange of ideas. This objective, and the stated goal of further reaching underrepresented groups, is fostered by the highly specialized, topical, and interactive organizational format of the ASN meeting.